Decision Support System for Personalized Care of Ventilated Patients using Esophageal Pressure

Project Summary
Mechanical ventilation is an essential intervention for many patients but is associated with a risk of preventable
complications and is a modifiable determinant of outcomes. Current standard of care approaches utilize non-
individualized “one-size fits all” strategies which may expose patients to ventilator induced lung injury (VILI) and
other complications often leading to prolongation of ventilation and mortality. We propose that better
understanding individualized respiratory physiology and patient-ventilator interaction using esophageal
manometry and decision support can create more personalized mechanical ventilation and improve clinical
information, ventilator settings and outcomes.
Using esophageal pressure (Pes) provides accurate estimations of transpulmonary pressure, respiratory effort,
intrinsic PEEP, and patient-ventilator interaction that can be used to prevent lung collapse, prevent lung injury,
and optimize lung mechanics and oxygenation. Most major mechanical ventilator settings can be better
optimized with the use of esophageal pressure.
Unfortunately, esophageal pressure measurements are typically labor intensive, require repetitive training for
proper placement, and parameters derived from them are not easily calculated or interpreted. Esophageal
balloons need to be properly placed and inflated and carefully watched over time to ensure and maintain
accuracy. For these reasons, Pes is not commonly used during mechanical ventilation, with most patients
receiving standard ventilator modes/settings.
In this grant, we propose to develop a patented system including decision support for the personalization and
optimization of mechanical ventilation by simplifying and expanding the use of Pes in the ICU. The system will
support the placement and inflation of the balloon, automatically monitor its accuracy over time, and calculate
and interpret key parameters. Our team has extensive experience with Pes and optimization of mechanical
ventilation.
We propose two Aims in this Phase I SBIR grant to reduce the risk of the technology.
Aim 1 – Build a prototype hardware and software system. Although some ventilators include Pes monitoring,
most do not, and those that do are still difficult to use. We will design a hardware and software decision support
system for all ventilators. The system will automatically inflate and monitor the balloon and obtain the required
airway data. The Phase I software system will provide placement support, accuracy monitoring, and decision
support for several key parameters.
Aim 2 – Validate the value and ease of use of the system. Our goal is to prove that the system simplifies use
of Pes and adds clinical value to ventilator care. We will use a Pes part task trainer and simulated patients to
evaluate the performance of 10 RTs both with and without the system and assess the usability and acceptability
of the system.
This Phase I grant will create and evaluate a prototype Pes decision support system that can significantly improve
usability and shows that the IntelliPes system has the potential to bring esophageal manometry into everyday
use, providing improved data and outcomes to many difficult to ventilate patients.

Public health relevance
PROJECT NARRATIVE Mechanical ventilation is an essential intervention for many patients but is associated with a significant risk of preventable complications including ventilator induced lung injury, ventilator associated pneumonia, extended ICU stay, and mortality. Esophageal manometry provides important physiologic data such as transpulmonary pressure, effort to breathe, patient-ventilator asynchrony, intrinsic PEEP, and other parameters that can reduce lung injury and shorten time on the ventilator, but its use is severely limited due to the time consuming and difficult effort required for proper use and interpretation. This project will develop a system including patented hardware and decision support software that will automate and simplify the use of esophageal manometry to improve accessibility and clinician adoption leading to personalized care of ventilated patients that can improve patient outcomes in the critically ill.